Regulation of Actin Polymerization Through Inhibition of Arp2/3 Complex by Arpin and Coronin

Project summary/abstract:
The goal of this proposal is to elucidate novel mechanisms of Arp2/3 complex inhibition by two protein inhibitors,
Arpin and Coronin, as dysregulation of this system cause muscle diseases such as cardiomyopathyand underpin
the invasive nature of cancer metastasis. Although mechanisms of inhibition have been widely studied, inhibition
has remained largely unexplored due to little progress towards the classification of direct inhibitors of Arp2/3
complex. In a major breakthrough, I biochemically and structurally characterized Arpin as an inhibitor of Arp2/3
complex by providing the first structure of Arpin bound to the complex. This seminal finding provided the
necessary insights to guide biochemical experiments towards precisely describing the mechanism of inhibition.
I found that Arpin binds the complex in a similar manner to activating proteins NPFs via structurally homologous
C-termini, with distinct but important differences that ultimately classify each protein as an inhibitor or activator,
respectively. In aim 1, I will continue this line of investigation by exploring the mechanism of inhibition through a
crosslinking assay that monitors conformational changes of Arp2/3 complex that will lead to the discovery of a
novel mode of inhibition. I will also investigate how post-translational modifications on Arpin influence Arp2/3
complex binding and inhibition, also studying in parallel the uncharacterized globular domain of Arpin through
structural and cell-based studies (accomplished through collaboration). In aim 2, I will apply the skills and
knowledge learned from aim 1 to investigate the long-standing proposed inhibitor Coronin, as there exists
conflicting reports on their activity towards Arp2/3 complex. I will take a representative member of the canonical
mammalian Coronins (Coronin 1A) and test its ability to regulate Arp2/3 complex function using a wide array of
biochemical, biophysical, and structural approaches. In aim 3, I will focus on the remaining and most unique
member of mammalian Coron ins, Coronin 7. Coronin 7 contains a potential Arp2/3 complex binding domain at
the C-terminus similar to NPFs and Arpin, but divergent from canonical Coronins containing a coiled-coil. If this
region interacts with Arp2/3 complex or branched actin networks is not known and is a main focus in this
proposal. Altogether, this work addresses gaps of knowledge in regard to inhibition of Arp2/3 complex, a process
that comprises half of the overall regulatory system that governs cell motility and vital intracellular processes.
The success of my aims depends mainly on my ability to executive the proposed experiments and produce pure
Coronin proteins, which I demonstrate in preliminary studies. My studies on Arpin position me to ask unique
questions on Arp2/3 complex inhibition investigated in this proposal. Accomplishment of the aims should have a
far-reaching impact, providing a shift in perspective on inhibitory mechanisms of Arp2/3 complex that will supply
information regarding how this system is disrupted in diseased states. This research will also serve to further my
training in the fields of biochemistry, physiology, and molecular biophysics.

Public health relevance
Project narrative: This project utilizes a combination of the most advanced biochemical, biophysical, and structural techniques to investigate mechanisms of Arp2/3 complex inhibition by Arpin and Coronins. A wide coverage of studies will reveal the mechanistic structure-function relationship that underpins inhibition, a critical component in Arp2/3 complex regulation that controls cell motility, tissue development, and muscle contraction. Mutations in Arp2/3 complex and its regulatory proteins have been linked to cancer metastasis, cardiomyopathies and vascular diseases, and the expected outcome is a better understanding of the mechanisms of inhibition that should inform strategies for treatment.